Mechanisms Regulating Complex Social Behavior

Project Summary
Social relationships among individuals shape many health outcomes. For example, social support systems
improve adherence to difficult treatment regimens, whereas dysfunctional social cognition exacerbates the
mental health challenges of depression and anxiety. In the previous period of support, our team provided
evidence supporting a two-stage model that cleaved the neural and computational processes that establish a
social context from those that guide subsequent social control. Those processes have been recently advanced
as part of a consilient, cross-species framework that explains adaptive decision making in social situations. Here,
we test the hypothesis that these processes reflect the core elements necessary for aligning behavior with the
current demands of the social environment. In this project, we will determine how social relationships, social
contexts, and the complexity of the social environment impact decision processes. Our three aims rely on tightly
integrated and theoretically well-motivated experiments that use primate electrophysiology, human
electrophysiology and neuroimaging, and manipulations of brain function; that adopt parallel tasks and social
context manipulations; and that analyze behavior through common computational models. Our work builds on
progress from the previous grant cycle that demonstrates how our team is uniquely positioned to achieve these
aims.

Public health relevance
Project Narrative We will use behavioral, electrophysiological, neuroimaging, and brain manipulation techniques to determine the mechanisms that mediate social competence—the processes that match behavior to the current demands of the social environment and which are often compromised in neuropsychiatric disorders like schizophrenia and diseases like HIV.